Medical Genetics Postdoctoral Fellowship

Contact PD/PI: Jarvik, Gail P.
Project Summary/Abstract
There is a national shortage of medical genetics scientists needed for the implementation of
precision medicine, and the discovery of treatments for hereditary diseases. Since its
beginnings in the late 1950s, the UW Medical Genetics Training Program has served as the
linchpin between the clinical and molecular sciences that has propelled this institution to a
position of academic leadership. Our graduates have made outstanding contributions to the
body of knowledge of genetic disease and occupy top faculty positions throughout the
international medical genetics research community. The UW Program offers comprehensive
research and didactic training in human genetics and genomics for physicians following
completion of residency training, and for Ph.D.'s in the basic sciences who seek a broader,
translational approach to human genetics and genome sciences. Training focuses on highly
collaborative mentor-based, research laboratory experience and is complemented with courses,
seminars, clinical conferences, journal club, and participation in national meetings. As they
progress, trainees are encouraged to apply for individual fellowship awards.
A diverse faculty with interests in clinical, mathematical, population, biochemical, molecular and
developmental genetics, bioinformatics, and genomics provides a unique environment for
preparing our trainees for careers in academic medical genetics. The fifty-six participating
faculty are primarily drawn from the two Medical Genetics units in the Departments of Medicine
and Pediatrics, and the Department of Genome Sciences. We have improved our training
program during the last funding period with : 1) a new combined 4-year Pediatrics-Medical
Genetics residency 2) new faculty mentors in the Adult and Pediatric Divisions of Medical
Genetics 3) renewal of established, externally-funded research programs and 4) new
multidisciplinary research projects such as the Brotman Baty Institute for Precision Medicine, a
new clinical site in the NIH Undiagnosed Diseases Network, and a sequencing center for the All
of Us research program. 5) improved recruitment and support of underrepresented minority
postdoctoral fellows. A specific focus of our program is to diversify the medical genetics
workforce by attracting underrepresented minority or disabled trainees to careers in medical
genetics. With the increasing integration of genetics into all medical specialties, we request
continued support for four funded positions per year for five years to enable the UW Medical
Genetics Postdoctoral Training Program to continue its successful mission of launching
academic, research-focused careers in medical genetics and genomics.

Public health relevance
PROJECT NARRATIVE The implementation of precision medicine requires physicians and scientists who have been trained to understand how genomic diversity in humans causes both rare and common diseases across the life span, and who are capable of translating that knowledge into clinical testing and new treatments to improve human health. This T32 program supports the training of the next generation of outstanding academic M.D. and translational Ph.D. investigators in medical genetics and genomics.